The Hematologic Malignancies Conference

SUMMARY/ABSTRACT
The goal of this R13 application is to provide partial support to the 2023 Scientific Research Conference on
Hematologic Malignancies administered by the Federation of American Societies for Experimental Biology
(FASEB). This biannual conference is the premier meeting in the field, and provides invaluable opportunities for
early-career scientists to interact with peers and leading established investigators in the field in a highly collegial
and intimate setting. Numerous established investigators in the field see their attendance at this conference
when they were trainees as pivotal to their career development, and the ability to help catalyze the career
development of young investigators is a major draw for established scientists to this conference. The provisional
scientific program highlights the most exciting science at the cutting edge of diverse sub-fields of hematologic
malignancies of deep interest to the scientific community. Major topics include 1) malignant hematopoietic stem
cell biology, 2) normal hematopoietic development, 3) clonal hematopoiesis and aging, 4) inflammation and
hematopoiesis, 5) the hematopoietic niche, 6) regulation of leukemogenic gene expression programs, 6)
metabolism and epigenetics, and 7) novel therapeutic strategies. Two keynote lectures from internationally
recognized leaders in the field bookend the conference. A number of presentation slots are specifically dedicated
to oral presentations by to junior investigators to be selected from abstracts. Poster Lighting Rounds provide an
opportunity for trainees to introduce the audience to their work during oral sessions, and ensure that the poster
sessions are one of the most interactive parts of the conference. The sole budgetary request in this R13
application is for 50% support of the registration and housing costs for all trainees (graduate students and
postdoctoral fellows) who will present oral or poster presentations at this conference.

Public health relevance
NARRATIVE The FASEB Scientific Research Conference on Hematologic Malignancies is the premier scientific conference focused on the biology and therapeutic targeting of hematological disorders. It brings together a critical mass of leaders in the field with exceptionally talented trainees in an intimate setting that is highly conducive to formal and informal scientific, mentoring and interpersonal interactions. The goal of this proposal is to leverage the thriving intellectual environment at this conference in order to catalyze the career development of trainees into future independent investigators who will lead the next generation of transformative advances in the field.